Repair of Focal Defects in the Annulus Fibrosus Using Injectable High-Density Col

DESCRIPTION (provided by applicant): Intervertebral discs (IVDs) in the spine consist of an inner nucleus pulposus (NP) and an outer annulus fibrosus (AF). Low back pain is a common problem that is often treated by surgically removing herniated disc tissue, leaving a defect in the AF. In order to return some function to the disc, several defect closure methods have been developed, such as sutures and barriers, which provide mechanical support for the defect but do not promote biological healing. Various tissue engineered approaches are currently being developed that employ biomaterials as scaffolds for AF-mimicking constructs. These advances are promising but their performance in an AF defect has not been reported. Our approach uses both in vitro and in vivo AF defect models to mechanically and biologically evaluate a biomaterial for AF repair. The AF is comprised of primarily type I collagen and collagen hydrogels have been used for many tissue engineering applications. As a gel, collagen is injectable and can be delivered easily to irregular defects; however, it typically exhibits low stiffness. Our lab has used collagen gels in a total disc replacement that exhibited good integration with surrounding AF tissue (Bowles et al., 2011). Therefore we chose type I collagen hydrogels as our platform for AF repair. We will assess the performance of collagen hydrogels for AF repair through three aims encompassing both in vitro and in vivo studies. The first aim will be to evaluate the effects of gel density and crosslinking on the mechanical contribution of collagen gels delivered to AF defects in vitro. It has been shown that the stiffness of collagen hydrogels increases with collagen density (Ibusuki et al., 2007). Likewise, crosslinking with a nontoxic agent like riboflavin increases gel stiffness. We will screen formulations with different collagen gel densities and riboflavin concentrations to find the combination that yields the stiffet gel, then mechanically test that gel in an AF defect. Aims 2 and 3 focus on long term AF repair and assessing collagen gel integration in an in vivo defect model. More specifically, the goal of Aim 2 is to evaluate the ability of unseeded collagen gels taken from Aim 1 outcomes to preserve disc height and NP content. Collagen gels for total disc replacement have shown increased integration when seeded with ovine AF cells (Bowles et al, 2011; Bowles et al., 2010). Therefore Aim 3 will focus on assessing the effect different cell densities on gel integration with surrounding native AF tissue. When these studies are complete, new methods for the assessment of injectable biomaterials will be established and the performance of high-density collagen for AF repair will be characterized.

Public health relevance
PUBLIC HEALTH RELEVANCE: Low back pain (LBP) is often caused by a herniated intervertebral disc (IVD), which can be treated with surgery. Current surgical treatments remove the damaged disc tissue but have no method to effectively repair the remaining defect. This project looks to create an injectable material for IVD repair that will restore mechanical function to the patient while promoting regeneration of the removed tissue. __SpecificAimsTextDelimiter__ Specific Aims In the United States alone up to $90 billion per year is spent on lower back pain, which is a leading cause of work disability (Dagenai et al., 2008). A primary cause of this pain and disability is bulging and herniation of the intervertebral disc (IVD). Herniated IVDs can be treated conservatively for some time, but require surgical intervention once the pain becomes debilitating. This treatment includes removing part of the native disc, resulting in a defect in the outer region of the IVD, called the annulus fibrosus (AF). Without repair of the AF, there is the possibility of re-herniation leading to additional surgeries (Chang et al., 2007). Mechanical methods for AF repair using sutures and barriers temporarily close AF defects, keeping the nucleus pulposus (NP) in place to slow degeneration (Chiang et al., 2010; Bron et al 2010). However, these treatments do not result in local tissue integration and biological healing. Clinical outcomes for repair are mixed, with some patients experiencing reherniation. Tissue engineering methods for AF repair offer promise for biological healing though the use of appropriate biomaterials such as collagen. For example, our group has used collagen hydrogels in tissue engineered IVD replacements, which exhibited good integration with native AF tissue (Bowles et al., 2011). As such, these collagen-based formulations are good candidates for local repair of damage to the AF. With this in mind, the goal of this work is to evaluate the use collagen hydrogels to mechanically and biologically repair defects in the annulus fibrosus. Rationale 1: Collagen is the main structural protein in mammalian tissues. There has been great interest in collagen scaffolds for tissue engineering applications. The AF is comprised primarily of type I collagen fibers that are severed in the case of surgical intervention or trauma induced herniation. Collagen can be delivered via injectable formulations, making it desirable for sealing of local defects. However, injectable collagen gels are generally weak and compliant (modulus<1kPa) which limits their utility for mechanical repair. Recent studies have shown that collagen gels can be made stiffer by increasing gel density (Cross et al,. 2010; Elsdale, 1972) or treatment with crosslinking agents such as riboflavin (Ibusuki et al., 2007). Our goal is to create a collagen hydrogel formulation that remains injectable but is stiff enough to seal defects in the AF. Hypothesis 1: Injectable high-density collagen gels will fill and remain in an AF defect under load while enhancing the mechanical behavior of damaged IVDs. Specific Aim 1: Evaluate the ability of collagen gels of varying density (5-20mg/ml) to heal defects in the AF and determine the effect of riboflavin-based crosslinking on repair of AF defects in vitro. Rationale 2: Published studies have shown that collagen gels will integrate with surrounding AF tissue when implanted in vivo (Bowles et al., 2011). In preliminary studies for Aim 1, we have shown that these gels remain in a defect after injection and restore some of the mechanical properties lost when damaged. With the previous studies of collagen gels in the disc space and our preliminary data with injectable high-density collagen gels, we believe that our collagen gel formulations will integrate with the AF in vivo to provide long term healing to the damaged region. Hypothesis 2: High-density collagen gels delivered to a defect in a rat caudal IVD will preserve disc height and healthy disc phenotype in vivo. Specific Aim 2: Evaluate the ability of high density collagen gels to repair AF defects in vivo using histological analysis for integration, radiological examination for NP content, and mechanical testing of motion segments. Rationale 3: Our total disc replacement constructs were seeded with ovine NP cells and AF cells in their respective regions. A histological evaluation showed ingrowth of tissue from the adjacent endplates to the construct as well as tissue within the construct (Bowles et al., 2011). Using a cell-seeded gel may promote similar results in the annulus fibrosus for repair. The goal of this aim is to use healthy AF cells to enhance repair of an annular defect. Hypothesis 3: Cell-seeded high-density collagen gels will enhance IVD repair in the defect site while maintaining mechanical support. Specific Aim 3: Evaluate the effect cell seeding on the integration of collagen gels with surrounding AF tissue though histological, radiological and mechanical comparison with unseeded gels. The proposed studies seek to evaluate the performance of high density collagen gels for repair of the AF in damaged IVDs. With successful completion of the three aims, we will show that injectable collagen hydrogels can be made stiff enough to repair AF defects mechanically and support tissue growth in the defect. Our approach will establish new methods for the assessment of injectable biomaterials for repair of AF injury and is translatable to a therapy to treat a leading cause of disability in adults.